The Botswana Cancer-HIV Care Assistance and Monitoring using Peers (CHAMPS)

PROJECT ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as “NOT-CA-
24-028”. Cancer presents a significant burden in low- and middle-income countries (LMICs), with Africa facing
a substantial share of this challenge. The Cancer-HIV Care Assistance and Monitoring using Peers Study
(CHAMPS) aims to address the pressing public health issue of cancer among people living with HIV/AIDS
(PLWH) by exploring the integration of cancer care into HIV care settings using peer support from expert
clients in Botswana, a low-resource country grappling with both HIV/AIDS and cancer burdens. Aim 1 will
investigates barriers and facilitators in cancer care cascade through a mixed-methods approach targeting
PLWH co-diagnosed with cancer and healthcare providers from public oncology centers and co-located
Infectious Disease Control Centers (IDCC). Aim 2 will assess the acceptability and feasibility of integrating
expert client support for cancer care cascade within the IDCCs. Overall, the proposed research will: 1) inform
the development of an R01 grant application for a randomized trial to investigate the effectiveness of
integrating expert client support for cancer care among PLWH in Botswana and 2) provide mentorship and
career development for Dr. Lillian Okui, MD, MPH, an early-stage low- and middle-income country investigator
(ESLI) to become an independent investigator in cancer implementation science. Her mentorship team will be
led by a highly experienced primary mentor (see Letter of Mentorship Support) and co-mentors who bring
expertise in implementation science, clinical HIV and cancer care, epidemiology, and qualitative research. Her
career development includes developing advanced research methodologies in design, and analytic techniques
for cancer research, receiving training in implementation science, enhancing publication and presentation
skills, expanding professional networks, and gaining skills in grant writing. Lastly, the proposed global cancer
research is aligned with mission of the Botswana Ministry of Health, the LMIC institution, and the sponsoring
institution, the University of Maryland School of Medicine and the University of Maryland Greenebaum
Comprehensive Cancer Center (see Letters of Institutional Support).

Public health relevance
PROJECT NARRATIVE The CHAMPS study seeks to address a critical gap in cancer care delivery for people living with HIV/AIDS (PLWH) in Botswana, a country facing significant burdens of both cancer and HIV/AIDS. By investigating barriers and facilitators in the cancer care cascade and assessing the acceptability and feasibility of peer support intervention using expert clients, this research aims to improve access to cancer care for PLWH, ultimately reducing morbidity and mortality in this population. The findings will inform evidence-based interventions and policies, contributing to improved health outcomes and quality of life for PLWH co-diagnosed with cancer in Botswana and similar resource-limited settings.